American Sign Language and Spatial Cognition Skills: A Neurocognitive Study Using EEG and Standardized Neuropsychological Assessments

Project Summary/Abstract
This research proposal focuses on the relationship between American Sign Language (ASL) fluency and spatial
cognition, an area encompassing skills like perspective-taking, spatial navigation, and orientation.Spatial cognition is
fundamental to everyday life, influencing how individuals interact with and understand their environment. ASL, a
language rich in spatial-linguistic elements such as handshapes, movement, orientation, and facial expressions, offers a
unique medium to study this relationship. This proposal posits that ASL's spatial-linguistic features, particularly its
classifier constructions, which depict objects, their orientation, and movement through space, may enhance visual-spatial
abilities in its users. By exploring these connections, we seek to uncover insights into the cognitive impacts of ASL use
and its potential implications for promoting better health, well-being, and healthy aging in Deaf individuals.
To investigate this, the study will employ electroencephalography (EEG) for its high temporal resolution, focusing
on the mu rhythm over the sensorimotor cortex. This approach aims to uncover how signers process spatial and motor
information during communication and how this translates to skills like navigation and perspective-taking.
The proposal sets forth two primary objectives:
1. Examine the Link Between ASL Proficiency and Non-Linguistic Spatial Tasks: This aim addresses how
proficiency in ASL, characterized by spatial expressions that require frequent perspective shifts, shapes spatial
cognitive abilities. It hypothesizes that fluent ASL users will demonstrate superior performance in
perspective-taking, navigation, and orientation tasks, marked by greater accuracy and efficiency.
2. Explore Neural Responses in Spatial Cognitive Tasks Among ASL and Non-ASL Users: This objective seeks to
understand the neural mechanisms behind spatial cognition in relation to ASL proficiency. It hypothesizes that
proficient ASL users will exhibit distinct neural patterns, particularly reduced sensorimotor cortex activity during
spatial tasks, suggesting more efficient processing of spatial information.
The significance of this research lies in its potential to reshape our understanding of the cognitive strengths of ASL users,
with implications for public health. Insights could inform educational and therapeutic approaches, leveraging ASL to
enhance spatial cognition in both deaf and hearing populations. This study not only aims to contribute to the academic
understanding of spatial cognition and language processing but also seeks to influence practical applications in cognitive
health care for diverse populations.

Public health relevance
This research project on the impact of American Sign Language (ASL) fluency on spatial cognition in Deaf individuals contributes to the fundamental knowledge of development and its application to enhance health. By examining the direct correlation between ASL proficiency and spatial reasoning skills, the study seeks to provide targeted insights for developing more effective cognitive interventions and diagnostic tools. These insights are particularly relevant for enhancing cognitive health strategies and educational approaches for the Deaf community, potentially leading to improved health outcomes and quality of life for Deaf individuals.